Genetics and Pathobiology of Disorders of Keratinization

PROJECT SUMMARY:
Disorders of keratinization (DOK) are severe, rare genetic skin disorders in which the central
barrier function of the skin is disrupted and a compensatory pathway of hyper-proliferation is
activated in either a localized area or throughout the entire skin surface. This results in a grossly
compromised epidermis that fails to adequately protect against bacterial, chemical, and
mechanical assault or to prevent transepidermal water loss. In early life, the consequences of
these disorders can be life-threatening, with increased susceptibility to infection due to blistering
and fissures, dramatically increased metabolic demands due to evaporative heat loss and
increased epidermal turnover rate, and various associated comorbid conditions and systemic
abnormalities which can persist throughout life. We and others have identified over 70 diverse
genes for these disorders, yet clinical experience and our data show that these genes explain
only a portion of heritability for DOK, which demonstrate marked locus and phenotypic
heterogeneity, with greater than 15% of subjects without mutation in known genes. In the last
funding period, we identified five new genes for DOK, provided evidence for phenotypic
expansion in two others, and identified a novel pathogenesis-directed therapy for one disorder.
We now propose to expand our large cohort of well-phenotyped DOK kindreds, to screen for
mutations in known causative genes, and to employ exome and genome sequencing in those
subjects without mutation in known DOK genes to discover novel genetic causes of these
disorders. We will employ patient-derived cells and tissue to interrogate the function of
identified novel genes, and will generate transgenic skin equivalents to study and prove
pathogenesis of identified mutations. For a limited number of novel genes not previously
implicated in DOK, we will generate mouse models using CRISPR technology to further
examine the effect of identified mutations on cutaneous function. These studies will continue to
identify molecular pathways central to the complex processes of epidermal differentiation and
self-renewal, and will provide critical context for more detailed future biologic studies.

Public health relevance
PROJECT NARRATIVE: The study of genetic skin disorders, including disorders of keratinization, has identified many pathways central to the normal function of the skin. We propose to employ exome and genome sequencing technologies to identify the remaining genetic causes of these disorders. This work will benefit public health, as gaining insight into genetic causes of these diseases will provide new information about how the skin maintains and renews itself, and may serve as the basis for creating new approaches to targeted therapy for both these rare disorders and related, more common, disorders within the population.